DEVELOPMENT AND CHARACTERIZATION OF AFRICANIZED HONEY BE

The northward migration from Brazil of the Africanized honey bee (AHB), Apis mellifera scutellata, following their accidental release presents a new U.S. public health concern. Because of the AHB's extremely defensive colony behavior, persons may be attacked by swarms resulting in hundreds to thousands of stings. In these instances, potentially lethal quantities of venom are delivered (similar to snakebite), with no commercial antivenom available to neutralize toxicity. It is projected that up to 6,000 individuals annually will receive serious stings in the U.S. following establishment of feral populations. Ophidian Pharmaceuticals herein proposes to develop an AHB antivenom using proprietary methods for the production of pharmaceutical-grade polyclonal antibodies from hyperimmune hen eggs. High-purity avian antivenoms have been shown to have superior venom-neutralizing capabilities when compared to conventional mammalian products and are expected to reduce inflammatory side effects. Hens will be immunized with whole bee venom followed by extraction of total hyperimmune yolk Ig and purification by affinity chromatography. The resulting antibodies will be characterized by in vitro immunochemical analyses and by venom neutralization in a mouse protection assay. Based on these feasibility studies, expanded formal development is anticipated to continue to fulfill pharmaceutical licensing requirements.